Cell Death

[unreadable] DESCRIPTION (provided by applicant): Programmed Cell Death encompasses many molecular and biochemical processes that were evolutionarily selected to promote self-elimination of cells. Programmed cell death is required for normal development and tissue homeostasis. Abnormalities in the regulation of cell death contribute to a wide variety of human disorders, including cancer, AIDS, stroke, autoimmunity and neurodegenerative disorders. Most if not all cells have the capacity to commit suicide, and key components of various cell death programs have been conserved in lower organisms, thereby providing powerful model systems for study. Some of the genes that regulate programmed cell death include oncogenes and tumor suppressor genes, providing a link between deregulation of cell death pathways and cancer. Many viruses encode genes that promote or inhibit cell death, indicating that subversion of this cellular process is an aspect of the pathology of virus infections. Rapid advancements in recent years have led to the identification of numerous genes and gene products involved in controlling programmed cell death, and the biochemical pathways that regulate cell death have begun to emerge. New evidence strengthens the link between cell death mechanisms and mitochondrial energetics. Model systems have permitted directed mutagenesis of cell death regulatory genes mammals, invertebrates and lower organisms, demonstrating the role of cell death in a wide range of cellular responses and disease states. The development of cell-free assays and the reconstitution of biochemical reactions from purified components have served to delineate some of the details of cell death pathways. Researchers in the field of cell death are a diverse group whose interests span invertebrate to mammalian developmental biology, neurobiology, tumorigenesis, immunology, infectious diseases, biochemistry, cell biology, structural biology, cell cycle control, transcription regulation, receptor signaling and DNA damage pathways. The Cold Spring Harbor conference on Programmed Cell Death will be held on September 26-30, 2007. The objective of this conference is to bring together researchers working in the diverse aspects of programmed cell death and to facilitate new discoveries. The meeting plan includes an opening address, eight plenary and three poster sessions, in which participation by junior scientists will be facilitated. The overall goal is to create a meeting environment suitable for the open exchange of information and ideas that will foster advancement of the field toward a full understanding and development of new therapeutic approaches. [unreadable] [unreadable] [unreadable] [unreadable]